Probing visual computations and electrical stimulation in the central macaque retina for high fidelity vision restoration

Project Summary/Abstract
Blindness resulting from photoreceptor degeneration is a leading cause of disability. A primary treatment option
is the use of epiretinal prostheses, which directly activate retinal ganglion cells (RGCs), sending artificial visual
signals to the brain. However, vision restoration with current-day epiretinal prostheses is limited, due to the
coarse-grained stimulation that fails to replicate natural, light-evoked RGC activation patterns. In natural vision,
~20 functionally-distinct RGC types communicate unique representations of the visual world to the brain
through coordinated and precise cell type-specific patterns of activity. Modern implants don’t produce
high-acuity vision in part because they fail to elicit naturalistic RGC responses, due to coarse and nonspecific
stimulation. The goal of my research is to determine how well vision can be restored in the central retina by
analyzing the responses of primate RGCs to visual and electrical stimulation.
To accomplish this goal, I will first conduct ex vivo experiments in the central retina of the macaque monkey
with visual and electrical stimulation while recording with a high-density multi-electrode array. After identifying
the major functionally-distinct cell types, we will then characterize their spatiotemporal light response properties
and determine how they differ from cells of the same types in the peripheral retina. I will also compare how well
features from natural images are represented by central and peripheral RGCs of the major types. Next, to
determine how well central RGCs can be electrically activated, I will determine the electrical receptive fields for
each cell as well as quantify the extent to which RGCs of each type can be stimulated selectively. We will then
test the degree to which RGCs of major types in the central retina can be activated without activating axon
bundles. To achieve better electrical access to RGCs in the central retina, I will test whether removing the inner
limiting membrane decreases stimulation thresholds and enhances selective activation. In cases in which
selective activation of RGCs is unattainable with single-electrode stimulation, I will test whether tri-electrode
stimulation can better focus the electric field on a cell of interest through current steering to enhance selective
activation. Finally, to estimate how well high-resolution vision can be restored with a future implant targeting the
central retina, we will develop a simulation by aggregating the visual and electrical response properties across
many data sets and perform image reconstruction analyses to quantify the structural details of images that can
be perceived.

Public health relevance
Project Narrative The goal of this project is to determine how well the neural code of the primate central retina can be reproduced using electrical stimulation and recording of retinal ganglion cells (RGCs) in the central retina at cellular resolution, for the development of a future retinal prosthesis to treat blindness. Using high-density multi-electrode arrays, we obtain recordings during visual and electrical stimulation of several hundred RGCs of types that convey critical information about the visual world to the brain. This work will reveal the neural encoding properties of major RGC types in the central retina as well as what patterns of RGC activity can be reproduced with electrical stimulation, which together will afford an understanding of the expected vision restoration quality that can be provided with a future retinal implant.